DMS/NIGMS 2: Building and Testing a Graph Theory Toolbox for Uncovering Redundant Pathways in Genetic Interaction Networks

Biological networks are powerful resources for the discovery of genes and genetic modules. For the
classical physical protein-protein interaction network, as well as for other types of pairwise association
data between genes or proteins that is organized according to homophilic principles, diffusion-based low
dimensional network embedding methods have proved quite powerful. While at a coarse scale, genetic
interaction networks, built from high-throughput epistasis experiments, also display some homophily in
their organization, at a fine scale, they display very different graph-theoretic structure that can be
leveraged to find mechanisms of redundancy and fault tolerance among biological pathways active in the
cell. However, the graph theoretic toolbox to analyze this fine-grained structure in genetic interaction
networks is still underdeveloped, compared with algorithms developed for analysis of the purely
homophilic biological networks.
Inspired by some of the tools and techniques used in graph theory to study vertex cuts in networks, we
propose to develop a more formal framework for categorizing the patterns of resilience and redundant
pathway mechanisms in genetic interaction networks, and new algorithms for discovering genes involved
in compensatory pathways. We will use our mathematical framework to computationally make phenotype
predictions for the results of gene knockout experiments with either unseen gene combinations or in
unseen environmental conditions. We will validate some of our predictions focusing on alternative
pathways for DNA replication and repair in Saccharomyces cerevisiae (baker's yeast). Since DNA
replication and repair are crucial pathways for cancer cell survival, identification of genes in those
subnetworks could reveal new cancer therapy targets. Discovery of new genes is important for a basic
understanding of cell functioning and to elucidate the cause of inherited genetic disease.
RELEVANCE (See instructions):
Saccharomyces cerevisiae is a foundational model system for studying mechanisms of resilience and
fault tolerance in the Eukaryotic cell, and the pathways for DNA replication and repair are sufficiently
evolutionarily conserved to make insights in these model systems relevant for understanding human
diseases that exhibit genome instability. Methods to target compensatory pathways are also an active
area of drug design, including in the search for personalized therapies customized by tumor in cancer.